HOW METHANE AFFECTS STRUCTURE OF INTERMEDIATE Q

We are requesting beam time to investigate how the presence of methane affects the structure of intermediate Q in M. tricosporium methane monooxygenase. We would like to determine when and how methane interacts with the diiron active site.